Regulation Of Childhood Growth

Growth limitation and aging Aging involves a gradual decline in physiological function throughout the organism, decreasing the ability to respond to stress and homeostatic imbalance, and increasing susceptibility to disease. The causes of aging are poorly understood. One mechanism that may contribute to aging is a progressive decline in the proliferative capacity of various cell types, including adult stem cells, which impairs tissue maintenance and regenerative potential. For example, with age, there is a declining ability of the liver to regenerate after partial hepatectomy. Declining proliferative capacity in many tissues does not begin during adult life but instead initiates much earlier. In embryonic and early postnatal life, many tissues show rapid replication, leading to rapid somatic growth. Subsequently, cellular mechanisms slow this robust proliferation, such that, by adulthood, most tissues have entered a quiescent state where proliferation occurs only as needed to replace dying cells. We recently found evidence that the mechanism responsible for this decline in juvenile cell proliferation involves a genetic program that is common to multiple organs and includes the downregulation of multiple growth-promoting genes with age. We hypothesized that the mechanisms that progressively restrain juvenile growth continue to progress into adult life, thus contributing to the decline in proliferative capacity associated with aging. Progression of the underlying proliferation-limiting genetic program might lead first to cellular quiescence in young adulthood, such that some cells can still proliferate when stimulated for tissue renewal, but then, during aging, continued progression of the program might further limit the proliferative capacity of cells to a level below that needed for tissue renewal. As an initial test of this hypothesis, we used expression microarray to compare changes in gene expression that occur in liver, kidney and lung of mice during adult aging with changes that occur in juvenile life, as somatic growth slows. We found that many of the changes in gene expression that occur during adult aging originate in early postnatal life, during the juvenile period of growth deceleration. Furthermore, bioinformatic analysis of these genes that showed persistent changes in expression, both during juvenile life and during adult aging, indicate that cell-cycle related genes are strongly over-represented. Thus, the findings support the hypothesis that the genetic program that slows growth in juvenile life in order to limit adult body size persists into adulthood, and may eventually hamper maintenance and repair of multiple organs and thus contribute to the aging process. This hypothesis might provide an explanation for the observation that small mammals generally undergo both aging and suppression of juvenile growth on a far shorter time scale than do large mammals. The hypothesis might also help explain why growth-inhibiting conditions such as caloric restriction, growth hormone deficiency, or insulin-like growth factor-I deficiency slow aging. We have previously shown that growth-inhibiting conditions slow the juvenile growth-limiting genetic program. This slowing of the program may then conserve proliferative capacity, and therefore slow aging. Mechanisms limiting skeletal growth Mammalian body length is primarily determined by bone elongation, which occurs at the growth plate. These cartilaginous structures are organized into three distinct layers -- the resting zone, the proliferative zone, and the hypertrophic zone. Growth plate chondrocytes undergo sequential differentiation from the resting to the proliferative to the hypertrophic state as their spatial position shifts. Bone elongation is rapid in early life but gradually slows with age, until growth velocity eventually approaches zero in adulthood. The decline in longitudinal bone growth with age is associated with functional, structural and molecular changes in the growth plate. These senescent changes include a decline in the chondrocyte proliferation rate, overall growth plate height, proliferative and hypertrophic zone heights, column density, and extensive changes in gene expression. Based on prior findings, we hypothesized that growth plate senescence is not simply dependent on time per se but rather depends on chondrocyte proliferation. Thus, for example, growth plate chondrocytes may have a finite proliferative capacity, which is gradually exhausted, leading to a decline in growth rate and other senescent changes in the growth plate. To test this hypothesis, we used a tryptophan-deficient diet to suppress growth temporarily in newborn rats. Afterwards, growth in these rats was allowed to recover by switching to a replete diet. We found that structural, functional, and molecular markers of growth plate senescence were delayed by prior tryptophan deficiency, indicating that the developmental program of senescence had occurred more slowly during the period of growth inhibition. Combined with previous findings using other models of growth inhibition, the cumulative evidence support the hypothesis that delayed growth plate senescence is a consequence of growth inhibition, which in turn suggests that growth plate senescence is not simply a function of time per se but rather depends on growth. We have also found evidence that growth deceleration in non-skeletal tissues is similarly driven by growth itself, indicating that growth in many tissues is fundamentally limited by a negative feedback loop. Regulation of skeletal growth by Indian hedgehog (Ihh) and parathyroid hormone-related protein (PTHrP) Indian hedgehog (Ihh) and parathyroid hormone-related protein (PTHrP) are secreted proteins that act as paracrine signals, participating in a negative feedback loop that regulates chondrocyte differentiation and proliferation. However, the role of these proteins has primarily been studied in embryonic growth cartilage. Postnatally, this region undergoes major structural and functional changes. To explore the organization of the Ihh-PTHrP system in the postnatal growth plate, we microdissected growth plates of 7-day-old rats into their constituent zones and assessed expression of genes participating in the Ihh-PTHrP feedback loop. Ihh, Ptch1, Smo, Gli1, Gli2, Gli3, and Pthr1 were expressed in regions analogous to the expression domains in embryonic growth cartilage. PTHrP, however, was expressed in resting zone cartilage, a site that differs from the embryonic source, the periarticular cells. We then used mice in which lacZ has replaced coding sequences of Gli1 and thus serves as a marker for active hedgehog signaling. At 1-, 4-, 8-, and 12-weeks of age, lacZ expression was detected in a pattern analogous to that of embryonic cartilage. The findings support the hypothesis that the embryonic Ihh-PTHrP feedback loop is maintained in the postnatal growth plate except that the source of PTHrP has shifted from its embryonic location in the periarticular cartilage to a more proximal location in the resting zone.